Integrative Brain Network-Based Analysis for Heterogeneous and Multimodal

PROJECT SUMMARY
This proposal develops state of the art approaches for addressing challenging questions related to the
neurobiological mechanisms affecting clinical outcomes of interest in the presence of heterogeneity represented
by underlying disease sub-categories and variability in symptoms and other relevant variables across individuals.
We focus on developing integrative approaches for brain connectome based analyses, which combines the multi-
modal imaging (e.g. fMRI and diffusion MRI) of brain function and structure, clinical and behavioral measures,
while accounting for heterogeneity across samples. Our goals involve important questions in neuroscience which
have received limited or no attention so far, such as estimating dynamic brain connectivity while incorporating
brain anatomical structure, and subsequently examining which dynamic functional connections drive the clinical
outcome, accounting for heterogeneity in terms of disease sub-categories when predicting the clinical outcome
based on brain measurements which lie on an underlying brain network, and investigating differences in shapes
of white matter fiber bundles which drive the clinical outcome. To address such challenging goals, we develop
state-of-the-art statistical approaches which incorporate significant innovations and rely on multi-modal
neuroimaging data and uses biologically informed priors which yield meaningful solutions. The motivating dataset
is the Grady Trauma Project, which contains neuroimaging, behavioral, and clinical data on subjects who were
exposed to trauma and developed some degree of PTSD. We will test our approaches on an external PTSD
validation dataset from the ENIGMA-PTSD-PGC consortium. Our methodology development will include
proposing novel approaches for (a) the joint modeling of multiple graphical models using network-valued
regression; (b) using brain anatomical knowledge to inform the estimation of dynamic connectivity and
subsequently using the dynamic functional connections to predict the clinical outcome of interest; (c) developing
novel approaches for the joint estimation of multiple regression models corresponding to varying subgroups while
incorporating network information characterizing the covariates, and (d) developing Bayesian approaches for 3-
dimensional shape estimation for fiber tracts in the brain using anatomically informed priors, and subsequently
using the shapes of the estimated fiber bundles to predict the clinical outcomes of interest. We also develop a
robust strategy for the validation of the proposed methods and we also provide an outline for developing software
and sharing them openly with researchers and interested parties. This application addresses several clinical
significant questions in neuroimaging research which have not been explored before due to the lack of state of
the art statistical methodology, and is expected to make important methodological, scientific, clinical and
translational contributions.
.

Public health relevance
PROJECT NARRATIVE The goal of this study is to develop comprehensive statistical methodology for integrative analysis of multimodal, heterogeneous datasets containing high-dimensional neuroimaging measurements as well as behavioral, clinical, exposure and demographic variables. We develop state of the art statistical methodology to address important and clinically meaningful issues in neuroimaging literature, with a key objective being to obtain more accurate solutions by incorporating prior network and biological knowledge while also accounting for heterogeneity via subgroup analysis. The integrative analysis relates to multimodal neuroimaging data and data corresponding to behavioral, clinical, exposure and demographic variables, while the heterogeneity stems from the fact that different individuals responds differently to similar levels of environmental exposure, such as trauma exposure in PTSD studies. Our approaches are motivated by PTSD studies but can be also applied more generally to other mental disorders where it is meaningful to account for heterogeneity and where multimodal neuroimaging data is available.